NAFLD Diagnosis and Outcomes

PROJECT SUMMARY
Nonalcoholic fatty liver disease (NAFLD) affects 25-30% of US adults and has a major impact on healthcare
burden and population health due to higher morbidity and mortality than the general population. Even though
NAFLD can progress to cirrhosis, decompensation, and liver cancer, these outcomes affect a small proportion
of patients, but there are no accurate methods that are accessible in primary care to identify these patients
early. The heterogeneity of clinical phenotypes, lack of universal screening, and risk-stratification approaches
lead to delayed diagnosis, phenotype-specific prophylactic or therapeutic intervention, and poor patient
outcomes. The long-term goal is to develop easily accessible methods for NAFLD screening and prediction of
disease trajectory. The objective of this application is to leverage large electronic health record (EHR) datasets
and analytics to enhance the early identification of NAFLD in general healthcare settings. The central
hypothesis is that targeted screening with machine-learning (ML)/artificial intelligence (AI) models applied to
longitudinal healthcare data (diagnoses, laboratory values, medications, anthropometrics, demographics) can
identify predictors of NAFLD risk and, subsequently, a progressive phenotype toward liver events. The
rationale that underlies the proposed research is that EHR-based clinical algorithms which identify NAFLD and
phenotype the disease trajectory will guide clinicians in selecting patients who need liver-related diagnostic
evaluation and enable timely intervention to prevent hard outcomes. Guided by strong preliminary data, the
hypothesis will be tested by pursuing two specific aims. In Aim 1, a predictive model for NAFLD will be
developed using retrospective data from a population-based EHR-linkage system with validated diagnosed
NAFLD and non-NAFLD controls by chart review. Among those with NAFLD, an EHR-based model to predict a
clinical phenotype at risk for future liver-related events or death will be developed, using death from other
causes as competing risk. In Aim 2, the two models will be validated and calibrated to screen for NAFLD in the
population and to predict a liver phenotype at early stage (steatohepatitis or stage≥2 fibrosis). In this aim, the
cohort will be prospectively enrolled from the community to undergo NAFLD screening by magnetic resonance
imaging and assessment of liver disease severity by biopsy. Lastly, an AI-based NAFLD care model using the
predictive models introduced in the EHR system will be implemented in the primary care practice to measure
impact on disease identification and management. The approach is innovative because it expands the
analytical toolbox beyond conventional methods and challenges the current clinical paradigm which targets
only late-stage liver disease identification. These multimodal EHR-based algorithms of NAFLD screening and
clinical phenotyping will serve as scalable and unbiased clinical decision-making tools that enable
personalized intervention, thereby fulfilling a critical unmet need in the healthcare burden of NAFLD.

Public health relevance
PROJECT NARATIVE The proposed research is relevant to public health because it will use innovative methods to incorporate predictors from longitudinal data, collected in routine clinical practice, into models that diagnose NAFLD and predict future risk of liver events, such as cirrhosis and related complications. Lack of screening methods in current clinical practice and absence of symptoms until late-stage lead to delayed diagnosis and poor patient outcomes; therefore, early diagnosis and prediction of disease trajectory at primary care level will enable timely intervention and selection of patients who need specialized testing and hepatology referral. The project is relevant to the NIDDK’s mission because it will create a sound clinical pathway management for the most common chronic liver disease affecting 80-100 million US adults, which will ultimately decrease health care burden and improve population outcomes.